A matrix metalloproteinase biosensor-functionalized metastasis-on-a-chip platform for evaluating adrenocortical carcinoma progression

Adrenocortical carcinoma (ACC) is an aggressive malignancy with a poor 5-year survival rate of 6% for patients
with metastatic disease. There are no targeted therapies for these patients. Unfortunately, current treatments
only slow disease progression for an average of 5 months, after which drug resistance quickly develops. As
such, there is a critical need to identify new targets of intervention and develop new treatments for ACC. ACC
can be characterized by significant heterogeneity both intertumorally between patients and intratumorally within
an individual tumor, making choosing an effective therapeutic strategy challenging. Several mechanistic
pathways have been identified that may correlate with disease progression: IGF2, Wnt/β-catenin (Wnt), and cell
cycle regulating pathways such as p53/retinoblastoma protein (Rb) are dysregulated in 90% of ACC, and
correlate with metastatic disease. Unfortunately, the intratumoral heterogeneity of IGF2, Wnt, and p53/Rb
dysregulation and its contributions to ACC tumor progression is unknown, although each of these pathways has
been implicated or correlated with tumor invasion, matrix metalloproteinase (MMP) expression, or metastasis in
other cancers. This lack of understanding can partially be attributed to the lack of appropriate preclinical research
models. Most attempts to generate ACC models have been unsuccessful. The small number of existing models
do not adequately reflect the oncogenic signaling pathways and intratumoral heterogeneity of human ACC. A
human-based ACC model system permitting functional and transcriptomic characterization of tumor
subpopulations following metastasis does not exist. To address these critical research gaps, we developed the
first patient-derived organoids (PTOs) from patient samples as well as an ACC metastasis-on-a-chip (MOC)
platform. Our MOC platform is an in vitro microfluidic system that incorporates tumor organoids, recirculating
fluid flow, and downstream tissue organoids, which can recapitulate aspects of metastasis from a primary tumor
site to metastatic sites. In addition, we have developed MMP peptide biosensor technology that integrates into
our organoids, enabling near-real time observation of MMP-mediated tumor cell invasion. We will deploy this
platform to sort tumor cells into metastatic/motile versus non-metastatic/less motile subpopulations for analysis
of expression of dysregulated pathways in ACC (IGF2, Wnt, and p53/Rb) and subpopulation heterogeneity
determined by single cell RNA sequencing. We hypothesize that IGF2, Wnt, and cell cycle dysregulation
correlates with increased metastasis kinetics and MMP activity in ACC PTOs deployed in our MOC platform.
Towards this hypothesis: Aim 1 will delineate metastasis kinetics, MMP activity, and proliferation of ACC PTO
cells; Aim 2 will define ACC intratumoral heterogeneity of critical oncogenic pathway dysregulation using single
cell-RNA-sequencing; Aim 3 will determine the relative importance of each driver pathway on metastatic potential
through drug-based inhibition. Upon completion of this project, we aim to both better understand ACC disease
biology and have an established model of ACC that can be deployed for preclinical studies.

Public health relevance
PROJECT NARRATIVE Adrenocortical carcinoma (ACC) is an aggressive malignancy with a poor 5-year survival rate of 6% for patients with metastatic disease and there are no targeted therapies for these patients. The failure to identify more effective treatments can partially be attributed to the lack of appropriate preclinical research models that accurately model ACC metastasis and support the key biological pathways implicated in ACC progression. To address these critical research gaps, we will use our newly developed patient-derived organoid (PTO) model of ACC from patient samples as well as an ACC PTO metastasis-on-a-chip (MOC) microfluidic platform with onboard biosensing of cell migration to determine the roles of IGF, Wnt, and cell cycle regulation-based signaling on ACC metastasis.